Hazmat Training at DOE Nuclear Weapons Complex

DOE Project summary This ICWUC seeks to continue the DOE site training delivered by teams of DOE
worker trainers at the four targeted sites (251 classes to 3,846 trainees). These sites are fully operational
and rely on onsite experienced worker trainers (Hanford, Oak Ridge and Kansas City) while Los Alamos
National Laboratory (LANL) utilizes an experienced local DOE worker trainer. The IAMAW is a significant
partner in these efforts representing members at three of these sites. The Center uses a range of adult
education principles and techniques that rely on the knowledge and experiences of the participants to
teach key principles in a non-threatening and engaging method that motivates trainees to improve their
worksites.
Classes to be presented include a range of HAZWOPER related classes including 5 day CERCLA course
(12 classes; 152 trainees); 16-Hour Bridge classes for workers transferring into regulated areas and RCRA
classes (16 classes, 200 trainees) with all covered workers taking an eight hour refresher class annually
(73 classes, 1,634 trainees). There will be respirator refreshers at Hanford (14 classes, 308 trainees) and
fall protection and confined space programs at LANL (94 classes; 1,220 trainees). DOE worker-trainers
from each site will deliver all training, a cost-effective resource to the contractor and local union and there
will be 8 trainer development classes for 112 trainers. This includes a DOE trainers’ exchange and we will
continue our collaborative work with other Grantees. We will continue our community outreach efforts that
need to be significantly expanded.
We will continue to assess the workplace changes the program has produced through the long term
evaluation of participants and trainers. Our recent publication shows that these trainers have become
invaluable resources that co-workers and managers frequently request their opinion on the appropriate
practices, procedures and equipment about health and safety concerns (at least monthly) and that a variety
of workplace changes have occurred through the trainers’ efforts. Trainers are commonly asked by other
workers about toxic effects of chemicals, respirators, gloves and other protective clothing and respirators.

Public health relevance
The ICWU, with the IAMAW, will continue to develop DOE worker trainers (on site recognized experts) at four facilities using adult education principles to teach key principles in a non-threatening and engaging method that motivates participants to become active in improving their worksites.